MFRPS Maintenance - Indiana Department of Health Food Protection Division

Summary
Over the next project period, The Indiana Department of Health (IDOH) Food Protection Division
(FPD) plans to continue implementing a risk-based manufactured food system to better direct its
regulatory activities toward reducing foodborne illness. IDOH FPD will maintain full conformance
with the Manufactured Food Regulatory Program Standards (MFRPS) while continuing to hold
high quality Food Protection Task Force (FPTF) meetings that serve industry and other
regulatory partners. Indiana will also begin its efforts towards the full adoption of the FSMA
Preventative Control (PC) for Human Food Rule through the Special Project.
IDOH FPD plans to enhance program functions to better serve Indiana businesses and the
public. Industry outreach will be increased through more one-on-one consultation services, and
partnerships with State universities to provide HACCP, PCQI, and other needed trainings to
high-risk processors and other businesses subject to full-PC requirements. Preventive controls
training, and high-risk process training will be required of all inspectors to broaden the State’s
knowledge base and regulatory oversight - furthering the State’s goal of becoming a more
valuable partner within the IFSS.

Public health relevance
Project Narrative The Indiana Department of Health – Food Protection Division is committed to maintaining high regulatory program standards. The objectives outlined in this proposal will enable the division to not only meet, but exceed these standards by shifting program resources to a more preventive and collaborative approach to food safety regulation and illness prevention.